SYMPATHETIC NERVE RESPONSE TO ALCOHOL IN NORMAL BORDERLINE SUBJECTS

Effect of acute alcohol ingestion on the regulation of sympathetic nerve activity and blood pressure in normotensive and borderline hypertensive humans.